Transgenic and Gene Targeting Core

Core C is a continuing core for Trangenic and Gene Targeting of Mice. In the next grant cycle Core C will assist Project 1 in constructing endothelial specific knockouts of SCAP and STATS on the LDL receptor null background.Core C will assist Projects 1 arid 2 in constructing HO-1 conditional and endothelial specific, knockout of HO-1 on the apoE null background. Core C will assist Project 3 in construction of a MGP-P64Q mutant mouse through gene targeting and will assist Project 3 in the generation of Abcc6-Wnt-promoterbeta- gal reporter double transgenic mice. Core C will provide consultation on breeding and colony management of transgenic mouse models to Project 4. Core C will assist Project 5 construction of, transgenci mice for testing atherosclerosis-related candidate genes. Core C will assist Project 6 with the construction of transgenic mice expressing dominant negatie NR4A receptor in macrophages. Core C will , also provide assistance to Core A in the characterization of primary cultues of mouse aortic endothelial cells by performing qPCR and Western blot analysis.These functions of Core C are essential to ensuring the efficient and cost-effective completion of the specific aims of all of the component Projects.

Public health relevance
The use of transgenic and gene targeting technologies allows the use of mice for the study of diseases of importance to human health.